Self-organizing synthetic human lungs on microchips to fight infection by RSV

Project Summary
RSV is a major global threat that accounts for a significant share of respiratory disease and
mortality among patients at risk. Infection by highly pathogenic RSV results in acute lung injury,
LRTI, and pneumonia-associated complications. As treatments for RSV are very limited in use
and efficacy, the development of physiological models of this disease is key to develop
therapeutics that limit infection by this virus and associated pathology. This proposal will capitalize
on RumiViro’s mini-lung platform that offers inexhaustible access to genetically matched
organotypic human lung tissue to model infection by respiratory viruses. This platform will be
deployed to model RSV infection in physiological lung tissue and identify therapeutics for this
disease at scale. We will first screen a collection of 23,000 compounds of a highly diverse
phenotypic library of bioactive compounds for their ability to mitigate infection by RSV. Hit
candidates will be further validated for their ability to inhibit multiple clinical strains of RSV in mini-
lungs and primary lung tissue ex vivo. This work will have transformative influence for the
subsequent development of therapeutics and will enable further validation of therapeutic
candidates based on drug metabolism, pharmacokinetic analysis, in vivo proof-of-concept and
lead optimization efforts in follow-up Phase 2 studies. This work will provide a highly efficient
framework for the identification and development of RSV therapeutics with the promise of finding
anti-infective therapeutics that mitigate the RSV-induced pathology in patients at risk.

Public health relevance
Project Narrative Respiratory syncytial virus (RSV) is a major cause of respiratory illness in young children, elderly and immunocompromised individuals, with millions of cases and thousands of deaths attributed to this virus every year. The rational design of RSV therapies will require an understanding of the lifestyle of the virus during its infection cycle of human lungs, which is the most vulnerable target organ in infected patients. We have generated for the first-time thousands of standardized synthetic human mini-lungs on microchips that we can infect with RSV virus and we propose to use sophisticated molecular, imaging, and computational approaches to identify treatments for RSV disease at scale.